REACH Center Administrative Core

PROJECT SUMMARY - ADMINISTRATIVE CORE
The Administrative Core aims to promote relevant research through funding and coordination of the
Developmental Core, Community Engagement Core, and Exposure Assessment Core. The Administrative
Core coordinates the REACH Center’s multi-institutional partnerships that achieve the Center’s goal of
leveraging the strengths of multiple institutions in the National Capital Region to bridge novel geospatial
datasets to health-protective solutions for climate-sensitive risk factors. The Core facilitates innovative
approaches for this partnership that draw from the complementary areas of expertise of the
participating institutions. The Director and Co-Directors, advisers, and support staff of the
Administrative Core will (1) provide leadership and governance of the Center; (2) provide administrative
and fiscal oversight and management; (3) propel innovative approaches to spark multi-institutional
partnerships across collaborating Center institutions; (4) drive collaboration and communication
between investigators and government and community partners, NIH, and the Research Coordinating
Center and Community of Practice. The Center’s management structure is organized into an Executive
Committee consisting of the Directors and Co-Directors of each Core plus one institutional
representative from each of the collaborating institutions (George Washington University, George
Mason University, Howard University, and Environmental Defense Fund). The Executive Committee will
receive guidance from an Internal Advisory Board and an External Advisory Board. The Administrative
Core will facilitate and coordinate activities across a Community Engagement Core, a Developmental
Core, and an Exposure Assessment Core. Administrative Core Co-Directors will serve as liaisons to each
of these Cores, providing a bridge between the Cores and the Administrative Core that enhances the
functioning of the Center. Our leadership team is disciplinarily diverse and unique, with expertise in
health sciences, atmospheric sciences, clinical medicine, biostatistics, and community health science.
With the Administrative Core leadership, the REACH Center cultivates a multi-disciplinary, collaborative
research team that has the capacity to successfully compete for action-oriented NIH research on climate
and health.